RFA-GH-19-003, Advancing infectious disease and response in Senegal

• Please see Concept note attached in the Research part for more information regarding the
Project Summary

Public health relevance
Project Narrative Project title 1: Seroprevalence and risk assessment of Dengue virus infections in Senegal This project responds to Project Category A- “Characterize Public Health Threats” under Disease Area 1 “Acute Febrile Illness” as specified in the Notice of Funding Opportunity. Project title 2: Infectious bloody diarrhea etiologies from surveillance sentinel sites in Senegal This project responds to Project Category A “Characterize Public Health Threats” under Disease Area 4 “Enteric Illness” as specified in the Notice of Funding Opportunity.